A Novel Neurofeedback Intervention for Photosensitivity in Mild Traumatic Brain Injury

Photosensitivity is one of the more common sequelae of TBI, with over 50% of TBI patients reporting some
level of photosensitivity in the acute and/or chronic stages. Photosensitivity can range from mild to severe and
can significantly impair social, physical, and cognitive functioning, as well as rehabilitation outcomes. While
spectacle chromatic filters (i.e., sunglasses or indoor tints) are conventionally used to alleviate symptoms, they
are not designed to resolve issues with photosensitivity and have been associated with lower symptom
recovery over time, underscoring the need to develop more effective, non-invasive treatment options that can
reduce or eliminate photosensitivity. Recent work has shown that neurofeedback interventions, such as Low
Intensity Pulse-Based Transcranial Electrical Stimulation (LIP-tES) may be effective in treating post-concussive
symptoms and a preliminary case study from our research group suggests that LIP-tES may also be able to
reduce photosensitivity symptoms in veterans with a history of mild TBI. This represents an important
opportunity to address an area of high priority to Rehabilitation R&D, namely “the development of technology-
based interventions for chronic painful conditions that negatively impact outcomes”. However, both the
mechanism by which LIP-tES alters brain activity and alleviates symptoms across a range of disorders remains
unclear as does the neurobiological basis of photosensitivity associated with mTBI and psychiatric
comorbidities commonly seen in today’s Veteran population. These knowledge gaps represent important
limitations both for the clinical characterization of photosensitivity in Veterans and development/optimization of
novel treatment options. This proposal will take an important first step in addressing these two important
knowledge gaps. Aim 1: Complete a preliminary study testing the feasibility and acceptability of a novel
LIP-tES intervention designed to reduce severity of PS in patients with a history of mTBI. Extending a
recent case study completed by our research group, we will continue investigation of this novel intervention by
completing a pilot study of LIP-tES for the treatment of PS in veterans with a history of mTBI. Across 12 LIP-
tES and 12 sham sessions we will track recruitment capability (participants screened vs. enrolled, attrition rates
and reasons for attrition), acceptability and suitability of the intervention, evaluate suitability of the sham
procedure we developed, and gain preliminary evaluation of participant responses to the intervention. Aim 2:
Assess neurophysiological markers of PS and changes associated with LIP-tES intervention using
resting-state fMRI. Half of the participants enrolled in the study will complete three MRI scans during the initial
visit, midway through the study, and after the last LIP-tES or sham session. Preliminary work from our
laboratory has identified a sparse connectome of regions that are predictive of moderate/severe PS ratings in a
polymorbid sample of veterans from the Translational Research Center for TBI and Stress Disorders
(TRACTS) longitudinal cohort study. Extending this work, we will test whether classification models using this
previously identified connectome will correctly identify individuals who report a reduction in PS after treatment
and whether connections are predictive of PS severity. We will further complete whole-brain exploratory
analyses to identify changes in resting-state functional connectivity across pre- and post-intervention scans
that are associated with changes in PS. By examining resting-state functional connectivity prior to and after
completion of LIP-tES, the proposed study aims to increase our understanding of the underlying
pathophysiological mechanisms of PS in mTBI and the mechanism by which LIP-tES may alleviate these
symptoms. We will further explore the impact of LIP-tES pre- and post-intervention on supplementary
measures of postconcussive symptoms, posttraumatic stress disorder, depression, anxiety, sleep, chronic
pain, and headaches in order to more broadly increase our understanding of the impact of LIP-tES on cortical
dynamics that underly these common comorbidities seen in today’s veteran population.

Public health relevance
Photosensitivity is common following a mild traumatic brain injury (mTBI) and can significantly impair functional rehabilitation outcomes. While sunglasses are conventionally used to treat symptoms, they are not designed to resolve issues with photosensitivity underscoring the need to develop more effective treatment options. Recent work has shown that neurofeedback interventions, such as Low Intensity Pulse-Based Transcranial Electrical Stimulation (LIP-tES) can be effective in treating post-concussive symptoms, but it remains unknown how LIP- tES interventions alter brain activity and whether this approach can help alleviate photosensitivity symptoms, specifically. This proposal will address these questions by conducting a pilot study on LIP-tES for the treatment of photosensitivity and collect resting-state functional neuroimaging scans before and after intervention. Results of this study may significantly improve functional outcomes for veterans living with photosensitivity and further our understanding of the pathophysiological mechanisms underlying photosensitivity in mTBI.